A Multi-Level Community Based Approach to PrEP Uptake for African American Women

Project Summary/Abstract A Multi-Level Community Based Approach to PrEP Uptake for African American Women. The proposed pilot study will focus on African American adult women at risk for HIV in geographic hotspots in Georgia and Kentucky. The goal of this project is to utilize a community- engaged approach will to adapt and implement a culturally appropriate intervention to inform and educate about PrEP , HIV testing, and condom use and provide peer navigation. The intervention will consist of an educational component and navigation services. Women will be enrolled in one of two arms of the study: ARM 1: Health Love + PrEP (HL + PrEP)and ARM 2: Health Love only (HL). The intervention will be implemented by trained peer Community Health Workers (CHWs). We hypothesize that the implementation of this intervention will result in increased PrEP utilization, increased HIV testing, increased condom use, and increased service utilization among adult African American women. The specific aims of the project are to: AIM 1: Utilize a CBPR approach to adapt an evidence-based sexual health intervention for African American women, ages 18 and up, at high risk for HIV in Georgia and Kentucky to include lessons on PrEP. We will conduct focus groups and in-depth interviews with community stakeholders, including African American women and staff from community-based organizations to adapt the Healthy Love intervention. Aim 2: To implement and evaluate the CBPR adapted intervention for adult African American women in Georgia and Kentucky. We propose to implement a two-arm, randomized controlled trial with 144 African American women (72 in Georgia and 72 in Kentucky) to compare HL + PrEP and HL. If successful, the proposed study will provide evidence for the utility of a CBPR approach to implement an adaptation of the evidence-based Healthy Living intervention that will contribute to Ending the HIV Epidemic in the US.

Public health relevance
Project Narrative Recent surveillance data in Kentucky and the Atlanta metropolitan demonstrate that African American women accounted for are disproportionately represented among new HIV cases. An effective intervention focused on PrEP uptake and peer navigation for African American women designed in collaboration with the community, may decrease the risk of HIV. The proposed study will provide evidence for the utility of using a CBPR approach to implement an adapted Healthy Love intervention that will have positive effects on risk factors associated with HIV/AIDS morbidity and mortality among African American women.